Molecular Biophysics Training Grant

Project Summary / Abstract
This proposal requests support for ten predoctoral trainees in the field of molecular
biophysics, drawn principally from the interdepartmental Graduate Group in Biophysics,
and the Departments of Chemistry and Molecular and Cell Biology. The 26 training
faculty are drawn from the foregoing and from the Departments of Physics,
Bioengineering, Chemical and Biomolecular Engineering, and Plant and Microbial
Biology. Our faculty are world leaders in their fields and include five members of the
National Academy of Sciences, five Howard Hughes Medical Institute Investigators, and
a recent recipient of the Breakthrough Prize in Life Sciences. The Molecular Biophysics
Training Grant is the only training program at UC Berkeley focussing on molecular
biophysics and the only training grant that supports graduate training within the
Graduate Group in Biophysics.
The goal of the program is to train future leaders in the application of the most
powerful physics-based technologies and concepts to the most intractable, medically,
and societally important problems. We have a sustained track record of producing
graduates who have become leaders in academia, industry, and government research
laboratories. We accomplish this with an integrated program whose four pillars are 1)
three laboratory rotations in the first year, followed by mentored research in the second
year and beyond; 2) core coursework in biophysical modeling and physical biochemistry;
3) career development through monthly lunch meetings, networking with internal and
external speakers, an annual retreat, and trainee conference attendance; 4) training in
ethical conduct and scientific integrity, rigor, and reproducibility.

Public health relevance
Project Narrative The Molecular Biophysics Training Grant supports a four-pronged approach to training future leaders in molecular biophysics through mentored research, core course work in biophysics and physical biochemistry, career development activities, and training in ethics and scientific integrity.